Role of impaired cognitive states & risk factors in conversion to mixed dementias

Project Summary/Abstract
Population demographic trends suggest an expected dramatic increase in age-associated
dementias and a looming public health crisis. Current emphasis is on disease prevention, with a
focus on older adults who express early cognitive impairment. The SMART (Statistical Modeling
of Aging and Risk of Transitions) has successfully harmonized data from nine different
longitudinal studies on aging involving records on 5,032 subjects, with 1,657 having autopsy
information. We propose to identify authoritatively the roles of diabetes and hypertension on the
occurrence and duration of pre-dementia states, as well as mixed pathology. The project has
shown that self-reported diabetes is not a risk for Alzheimer pathology but is a risk for
cerebrovascular pathology, that subjective memory complaints are a risk for a future cognitive
impairment, and that transitioning to a subjective complaint or even to mild cognitive impairment
is no guarantee of future dementia. The SMART renewal proposes to obtain Medicare claims
data on its participants to determine the severity of diabetes, hypertension and other
comorbidities that have not been investigated, such as renal disease, with a focus on improving
the prediction of who is at risk for a transition to an impaired cognitive state and mixed dementia
pathology. This will be accomplished through the following specific aims:
Aim 1. Update and extensively revise the existing SMART project database with additional
participant data; obtain and integrate linked Medicare claims data; assess agreement between
self-reported medical history and claims data. Aim 2. Investigate the relationship of HTN, T2DM,
and multimorbidity in advanced old age with AD and non-AD neuropathologies. Aim 3. Investigate
the relationship of HTN, T2DM, and multimorbidity in advanced old age with cognitive states
including subjective memory complaints, mild cognitive impairment, and dementia.

Public health relevance
Project Narrative With the graying of America, the cost of caring for older adults with dementia will rise substantially over the next few decades. Current emphasis in the field is on primary and secondary prevention. This project will study diabetes and hypertension as risk factors for various forms of dementia inducing pathology, as well as the impaired clinical states that precede diagnosed dementia.